Anticancer peptide therapeutics

Despite an exponential increase over decades in research and development (R&D) expenditures by the pharmaceutical
industry, the average number of new drugs approved annually by the FDA, 25 or so, has remained stagnant. The
unsustainable trend of runaway spending in R&D directly contributes to skyrocketing health care costs across the
country, underscoring an urgent need for new drug targets and classes. Protein-protein interactions (PPIs) control all
aspects of cellular processes and are considered to be the “Holy Grail” in drug discovery and ultimate drug targets for
disease intervention. Unfortunately, neither of the two major classes of existing drugs – low molecular weight compounds
and antibodies are effective in interfering with intracellular PPIs. On the other hand, although small peptides are capable
of effectively disrupting PPIs, they generally lack drug-like properties due primarily to their susceptibility to proteolytic
degradation in vivo. A sensible solution to this long-running enigma in drug discovery is side chain-stapled L-peptides
and proteolysis-resistant D-peptides. Antagonizing MDM2/MDMX to activate p53 is one of the most promising
therapeutic paradigms for anticancer therapy. We have recently developed a series of high-affinity L- and D-peptide
antagonists of MDM2 that effectively suppress tumor growth in vitro and in vivo in a p53- and MDM2-dependent
manner. To achieve sustained and robust p53 activation and optimal therapeutic efficacy, however, dual-specificity
antagonists of both MDM2 and MDMX are needed. The overall goal of this proposed research is to develop ultrahigh-
affinity, dual-specificity, and proteolysis-resistant peptide antagonists of MDM2 and MDMX as a powerful p53-
activating modality for the treatment of acute myeloid leukemia – where mutations of the TP53 gene are rare and MDM2
and MDMX are often amplified or over-expressed. This project may lead to the addition of new weapons to the existing
anticancer arsenal and broadly impact the development of peptide therapeutics for targeted molecular therapy of many
other diseases as well.

Public health relevance
Acute myeloid leukemia (AML), with 20830 new cases and 10460 deaths estimated in 2015, is a relatively rare cancer in the US. Despite a high rate of remission following initial chemotherapy, more than half of those AML patients who attain remission will relapse within three years, attributing to a 5-year overall survival rate of only ~25%. It is now known that genotoxic chemotherapy itself also induces AML relapse due to DNA damage and mutation. New therapies, particularly those without genotoxic effects, are needed for improved AML treatment. Targeted molecular therapy is superior to chemotherapy as the former aims to kill tumor cells while sparing normal cells by targeting specific proteins or signaling pathways that either promote or suppress tumorigenesis. One of the most promising molecular targets for anticancer drug discovery is the tumor suppressor protein p53. The proposed research aims to develop a novel anticancer strategy where potent peptide activators of p53 as tumor-killing agents are delivered via a tumor-recognizing monoclonal antibody into cancer cells, but not normal cells, for targeted molecular therapy of AML.